Virtual reality at the point of care to increase uptake of MOUD in the ED

PROJECT SUMMARY
Despite the widespread efforts to curb the opioid epidemic, the number of drug overdose deaths increased by
nearly 30% from 2019 to 2020, of which approximately 75% involved an opioid. NIH and SAMHSA have
directed significant funds towards improving access to increase the numbers of persons with opioid use
disorder (OUD) receiving treatment. However, the treatment gap continues to grow, with only a small minority
of eligible patients taking opioid agonist therapy (OAT). Although curbing the epidemic will require efforts
across multiple sectors, an immediate goal is to increase adoption of strategies already proven to be effective.
Initiating buprenorphine in the emergency department (ED) is an important low threshold strategy to improve
access, yet it remains grossly underutilized. Interventions aimed at decreasing system and provider level
barriers have not increased uptake. Therefore, increasing ED-initiated buprenorphine rates will likely not be
realized unless patient level barriers (i.e., preferences) are explicitly addressed. The objective of this proposal
is to develop and test a novel approach using virtual reality (VR) to increase uptake of buprenorphine in the
ED. We hypothesize that participating in an immersive VR experience may be more effective than currently
available counseling approaches and decision aids based on the superior ability of VR to activate emotional
responses compared to other media or motivational approaches. Our intervention is based on the Emotion-
Imbued Choice model which describes the multiple effects of emotion on decision making and behavior. For
example, positive affect enhances flexibility and willingness to examine alternative options, and activation of
positive affect is a consistent finding of VR exposure in health-related applications.
During the R21 phase we will employ a stakeholder-centered and user experience iterative design approach to
develop and optimize an immersive VR experience designed to motivate patients with moderate to severe
OUD to agree to treatment with buprenorphine while in the ED. During the R33 phase, we will conduct a
parallel, 2-arm, randomized controlled feasibility trial. The data generated from the feasibility trial will determine
the feasibility of performing a definitive full-scale randomized controlled trial (RCT) to ascertain whether VR-
Choice increases the rate of ED-initiated buprenorphine compared to TAU.
Eligible participants will be randomized 1:1 to VR-Choice or treatment as usual (TAU). We hypothesize that
this feasibility RCT will meet prespecified process criteria justifying a full-scale RCT. The five process
indicators are average number of eligible patients randomized per month, baseline measure completion,
proportion randomized to the VR-Choice arm completing the VR program, proportion in VR-Choice arm
developing VR-related symptoms, and acceptability of VR-Choice. Each of these process indicators will be
evaluated by preset “Stop” and “Go” thresholds. We will conclude that a full-scale RCT is not feasible if one or
more process criteria meet the Stop threshold.

Public health relevance
Narrative Despite widespread recognition of the benefits associated with opioid agonist therapy, few persons with opioid use disorder (OUD) who need treatment are currently taking either buprenorphine or methadone and the prevalence of OUD and number of overdoses continues to escalate. A landmark study has provided high certainty evidence supporting the initiation of buprenorphine in emergency department (ED), yet uptake remains low. The objective of this proposal is to develop and test VR-Choice, an immersive virtual reality experience designed to motivate eligible patients to agree to treatment with buprenorphine in the ED.